Longitudinal Imaging of Cortical Small Vessel Network Structure with Two-Color Multiphoton Fluorescence Microscopy

Project Summary
Although the small vessel consequences of type 2 diabetes in peripheral organs are fairly well
understood, the effects of diabetes on cerebral microvasculature are largely unknown. A
significant impediment to understanding these changes has been the technical challenges
associated with complete three-dimensional mapping of small vessel network topology in vivo.
The technical challenge lies in the ability to capture vessel morphology on the capillary scale while
also spanning the entire cortical thickness and extending into the subcortical regions. Further
complicating the technical challenge is the fact that vessel networks vary significantly in baseline
structure and response to pathological perturbations across animals, thus vessel networks must
be followed longitudinally to capture these dynamics. Therefore, the goal of this proposal is to
overcome these technical limitations by developing new optical microscopy techniques that permit
complete 3D mapping of the entire cortical microvascular network structure in vivo, and to use
these techniques to quantify chronic alterations in cerebral microvasculature associated with type
2 diabetes in mice. We will introduce new advances to two- and three-photon fluorescence
microscopy that will significantly improve our ability to image microvascular networks in vivo at
depths up to 1.5 mm over large spatial extents of mouse cortex. We will develop a new spatially
offset two-color multiphoton excitation approach that utilizes recent advances in long wavelength,
synchronized ultrafast lasers. The large-scale images of cortical and sub-cortical vasculature will
allow full 3D vectorization of vascular networks that will enable detailed analysis of the
microvascular morphology over time. We will use this combination of advanced in vivo
microscopy, novel ultrafast lasers, and computational analysis of vascular networks to quantify
the structural changes in cerebral microvasculature associated with type 2 diabetes.

Public health relevance
Project Narrative Diabetes affects millions of people worldwide, and there is considerable evidence that diabetes causes disturbances in the vascular system throughout the entire body, including the brain. The effects of these disturbances include heart disease, diabetic retinopathy and neurological consequences. Although the relationship between small vessel disturbances and diabetic complications are well understood for most parts of the body, their effects on the brain are poorly understood. In this project we will develop new technologies for directly visualizing the structure of small vessels in the brain and use these tools to understand how diabetes affects small blood vessels in the brain.